CORE INFRASTRUCTURE TASK ORDER FOR CISNET CONSORTIUM FOR CANCER SURVEILLANCE MODELING SUPPORT

The Contractor shall work with the National Cancer Institute (NCI), Division of Cancer Control and Population Sciences (DCCPS) to provide technical and logistical support to facilitate collaborative efforts of the CISNET Consortium in cancer surveillance, including cancer simulation modeling using a multicohort approach, flexible broad-based natural history models of cancer, and comparative modeling managed through a web-based Knowledge Management System with adaptable data structures.